Multidimensional predictive modeling to understand mechanisms of exercise response heterogeneity in older adults

Aging-related functional declines are thought to be caused by hallmark biological processes that ultimately
compromise healthspan and quality of life (QoL). Exercise is a multipotent treatment with promise to mitigate
most aging hallmarks, but there is substantial variability in individual exercise responsiveness. This inter-
individual response heterogeneity (IRH) was first identified in the context of endurance training (ET) and later
we established it with resistance training (RT). We propose the innovative, but logical, strategy to use combined
ET and RT aligned with HHS guidelines to maximize health benefits in aging adults. Low cardiorespiratory
fitness (CRF; VO2max) and low functional muscle quality (fMQ; strength/muscle mass) are multi-system
manifestations of the deterioration of the cellular hallmarks of aging. Importantly, both CRF and fMQ are
modifiable with ET and RT. Thus, our design premise is that combined ET+RT is an excellent strategy for
elucidating factors underlying IRH, as it forges a path toward understanding and mitigating IRH in aging with
direct translatability to best-evidence public health recommendations. While sources of IRH are a constellation
of modifiable and non-modifiable factors, we will test the hypothesis that factors central to aging itself – aging
hallmarks such as proteostasis, mitochondrial energetics, inflammation, and circadian clock function – are chief
contributors to the multidimensional circuitry that determines whether an individual achieves the minimum
clinically important difference (MCID) in CRF and/or fMQ with exercise training. We will also test the hypothesis
that altered exercise dosing coupled with lifestyle recommendations will promote attainment of MCIDs among
older adults who do not initially respond. With CRF and fMQ as primary clinical outcomes, we will use a 2-phase
Sequential Multiple Assignment Randomized Trial (SMART) of combined ET+RT with clinical phenotyping and
blood/muscle molecular and cellular analyses. Specific Aim 1: Interrogation. In SMART Phase I, N=200
participants stratified by sex and age group (60-69 vs ≥70 y) will enable testing of both as biological variables.
After 12 wk of ET+RT including acute response studies, individual responder classification will be defined by
MCIDs for CRF and fMQ. The impact of aging hallmarks (muscle proteostasis, mitochondrial function,
inflammation, circadian clock function) will be determined, and we will decipher the multidimensional circuitry of
IRH via integrated modeling of: (i) targeted cellular/molecular outcomes; (ii) inter-tissue communication; (iii)
epigenomics; (iv) free-living behavior; and (v) clinical outcomes. Specific Aim 2: Mitigation. In SMART Phase
II (10 wk), individuals not attaining one or both MCIDs will undergo an additional 10 wk of training with targeted
augmentation. Those attaining both MCIDs in Phase I will be randomized to: (i) continue the supervised training;
or (ii) return to free-living. The latter will enable us to test sustainability over 10 wk. We anticipate these aims will
foster significant advances in the understanding of factors impacting exercise response variability among older
adults by determining the role of aging hallmarks and defining multidimensional circuitry of influential features.

Public health relevance
Aging-related functional declines are thought to be caused by hallmark biological processes that ultimately manifest in physical, mental, and metabolic impairments that compromise healthspan and quality of life. Exercise is a multipotent treatment with promise to mitigate most aging hallmarks, but there is substantial variability in exercise responsiveness. Combining endurance and resistance training in alignment with public health guidelines will be used to better understand variable exercise responsiveness in older adults with the ultimate goal of improving each older adult’s capacity to attain the many health benefits of exercise.